Evaluation of the Sensitivity to Endocrine Therapy (SET ER/PR) Assay to predict benefit from extended duration of adjuvant endocrine therapy in the NSABP B-42 trial

ABSTRACT
The SETER/PR index of sensitivity to endocrine therapy measures endocrine receptor-related transcription from
formalin-fixed paraffin-embedded tumor sections and is highly reproducible within and between laboratories.
SETER/PR values correlate with the ligand binding activity of estrogen receptors and progesterone receptors,
predict early pharmocodynamic response to endocrine therapy and prognosis following endocrine therapy in
palliative and adjuvant treatment settings. Secondly, SET2,3 index adjusts the measurements of SETER/PR
index for baseline prognostic factors, enabling the assessment of endocrine-related transcriptional activity in
the context of baseline prognostic risk. Both indices add independently prognostic information to contemporary
genomic tests, likely due to stronger prediction of the cancer’s sensitivity to endocrine therapy.
The NSABP B-42 trial compared extended duration of adjuvant endocrine therapy with letrozole for 5 additional
years, versus placebo for 5 years, in patients who had completed 5 years of adjuvant endocrine therapy.
Extended endocrine therapy demonstrated improved disease-free survival at 10 years from randomization,
although there was no difference between treatments during the initial 4 years. To-date, correlative science
studies from NSABP B-42 have evaluated the Breast Cancer Index 2-gene ratio of HOXB13/IL17BR
expression, the 70-gene MammaPrint assay, and normalized ESR1 gene expression scores from the 21-gene
Recurrence Score. All failed to demonstrate predictive interaction in their respective primary analyses,
although exploratory analyses suggest that prediction will be possible with a more specific biomarker.
We hypothesize that SETER/PR index will predict benefit from extended letrozole therapy (ELT) in hormone
receptor-positive HER2-negative breast cancer. Specifically, that ELT offers most benefit to patients whose
breast cancer has a moderate degree of endocrine sensitivity. Our primary analysis plan is to test whether
SETER/PR index between 1.10 and 2.10 (inclusive) has significant interaction with lower rate of breast cancer-
free interval (BCFI) from extended letrozole treatment. This represents an inter-quartile range from a similar
population to NSABP B-42. Secondary analyses will evaluate other endpoints, subtypes defined by nodal
status or prior tamoxifen treatment, and other cutpoints of SETER/PR index. Secondly, we will evaluate SET2,3
for long-term risk of late relapse in patients from each treatment arm.
Clinically, a robust predictor of benefit from extended duration of endocrine therapy will be useful, as 10 years
of treatment is too long for many patients to tolerate and the absolute rate of benefit is small in the overall
population with hormone receptor-positive breast cancer. Current evidence shows SETER/PR index to be an
independently strong predictor of tumoral sensitivity to endocrine therapy, and associated prognosis, with
strong potential to predict who is likely to benefit from longer duration of endocrine treatment.
1

Public health relevance
NARRATIVE We will test the clinical validity of measuring sensitivity to endocrine therapy (SETER/PR index of gene expression) in archival primary breast cancer samples to predict whether a patient with hormone receptor-positive HER2-negative breast cancer will benefit from an additional 5 years of endocrine therapy. A CLIA-certified laboratory at MD Anderson Cancer Center will measure SETER/PR index in the primary tumor samples from NSABP B-42, a placebo controlled, randomized trial of 5 years extended letrozole treatment, versus placebo, for patients who had completed 5 years of a standard endocrine therapy. The primary analysis will test whether SETER/PR index values in the range 1.10 to 2.10 predicts longer breast cancer-free interval in the patients who received extended letrozole treatment, versus placebo treatment.